Air Pollution, Coronary Events and Atherosclerotic Progression in a Susceptible Population

Abstract
Cardiovascular health is a global public health priority. Atherosclerosis is the most common form of coronary
heart diseases (CHD) which constitutes 17.5 million deaths worldwide annually. Globally, both outdoor and
indoor air pollutants are known as major contributors to the burdens of CHD. Despite population-based
evidence suggesting that exposure to ambient air pollutants and use of solid fuel for cooking causes increased
mortality from CHD, there is little known about the impact of air pollution on CHD morbidity and progression.
For example, the extent to which exposure to air pollution accelerates atherosclerosis, initiate plaque instability
to rupture and develop coronary events, and the mechanistic pathways underneath are largely unknown. A
better understanding of air pollutants as potential factors to the development and progression of this pervasive
disease will be valuable for public health protection strategies, especially for susceptible population such as
patients with atherosclerosis. Here we propose a longitudinal cohort study and present an overarching
hypothesis that long-term exposure to air pollutants alter coronary biological process, accelerate disease
progression, and contribute to CHD morbidity and mortality. This study builds upon a well-selected 3500
patients with atherosclerosis in Beijing retrieved from an existing cohort and will add two waves of clinic visits
in 1100 subpopulation to examine disease progression. The cohort includes extensive data of novel subclinical
markers from computed tomography angiography (CTA) reflecting plaque morphology, plaque vulnerability,
vascular stenosis, and coronary inflammation, and also collects biomarkers related to their mechanistic
pathways. We also propose to add state-of-the art air pollution exposure assessment to determine individual
level of outdoor and indoor air pollution exposure of the highest quality to address our study hypotheses.
Firstly, we will determine the impact of outdoor and indoor air pollution exposures on coronary events and total
cardiovascular mortality. Secondly, we will investigate the effects of exposure to air pollution on atherosclerosis
progression and high-risk plaque formation characterized by CTA outcomes. Thirdly, we will examine the
effects of air pollution on biological markers of inflammation pathways and explore whether these pathways
mediate any response of disease progression to air pollution exposure. Lastly, we will take the unique
opportunity of the most stringent regulation period on air pollution in Beijing and assess whether long-term
decline in ambient air pollution change the worsening of the disease progression and biological responses as
our secondary hypothesis. Apart from the main analysis, we will also explore the potential of joint effects of air
pollutant mixtures and independent effects of air pollution exposure from traffic noise on CHD. Findings from
this study will not only extend scientific knowledge on air pollution and CHD physiopathology, but will provide
information to guide public policy and inform clinical management for individuals at-risk of CHD.

Public health relevance
Project Narrative Air pollution remains a ubiquitous exposure worldwide and is an important potential risk for coronary heart disease, the leading cause of death worldwide, through which atherosclerosis is the most common pathway. The precise consequences of exposure to air pollution on coronary heart disease remain uncertain, the responsible air pollutants, and the mechanisms underlying the effects are largely unknown: long-term exposure to outdoor and indoor air pollutants may make susceptible patients with atherosclerosis more likely to develop and promote coronary atherosclerosis with thickening and calcification and cause rupture and thrombosis of vulnerable plaques, leading to coronary events. This project holds the promise to generate new knowledge about modifiable environmental factors that may contribute new approaches to developing effective prevention modalities.